Center of Comparative Medicine and Pathology

ABSTRACT
The Center of Comparative Medicine and Pathology (CCMP) supports animal model use in cancer research
through its Research Animal Resource Center (RARC) and Laboratory of Comparative Pathology (LCP). At
MSK, animal models are used in basic and applied investigational studies as well as for training of both clinical
and research staff. Animals are employed in diverse areas including the development of new methods for
diagnosis and treatment of cancer as well as the elucidation of the basic biological mechanisms resulting in
neoplasia. CCMP’s professional and paraprofessional staff (163 FTE) serve as a consultative and technical
resource for MSK investigators on all matters related to animal research. RARC comprises five sections: 1)
Aquatic Systems and Services; 2) Biosecurity; 3) Education and Quality Assurance (EQA); 4) Husbandry and
Operations (H&O); and, 5) Veterinary Services (VS). RARC provides housing for and humane care to over
170,000 animals daily, utilized by 122 investigators. RARC’s oversight of MSK’s AAALAC-accredited, centrally
managed animal care program ensures the efficient use of available space and staff resources and allows for
close professional monitoring of the animal research program. Aquatic Systems and Services maintain the
housing systems and provide husbandry and technical services in support of MSK’s zebrafish colonies.
Biosecurity ensures that MSK’s rodent colonies remain pathogen free by routinely surveying colony health and
quarantining incoming rodents from vendors. EQA administers an extensive educational program that provides
training to animal care and research staff via didactic and hands-on sessions, web-based tutorials, as well as
written instructional materials. RARC’s H&O section operates two specialized state-of-the-art facilities
encompassing ~73,700 net square feet of space that provide critical environments and the specialized
equipment necessary for the maintenance and use of a variety of animal models. VS’s staff ensures that all
animals receive appropriate clinical care and perform technical procedures for research staff. The LCP, a multi-
disciplinary pathology laboratory, and its Genetically Engineered Animal (GEA) Phenotyping Service, support
individual laboratory’s research and RARC’s programs by providing clinical and anatomic pathology services
and extensive phenotypic profiles of GEA.